Automated system for LCMS sample preparation

Project Summary/Abstract
Wayne State University Lipidomics Core Facility provides Liquid Chromatography –
Mass Spectrometry (LC-MS) based lipid analysis services to NIH-funded researchers
both at the university and its partnering institutions. An essential feature of lipidomic
analysis is that the lipids are extracted from biological samples before subjecting to LC-
MS analysis. This is a labor-intensive process and involves repetitive use of Solid
Phase Extraction (SPE) as well as liquid-liquid extraction methods. The requested
automated system from Hamilton, MassExtract STARlet, can perform the essential
functions involved in the sample preparation for LC-MS. Precise volume delivery, mixing
and incubation, temperature control, barcode enabled sample monitoring, clog detection
systems, eluate evaporation, and other features of the system are invaluable to manage
large volume of samples (>6,000) processed by the core facility each year. This system
will revolutionize our ability improve accuracy, reproducibility, and the speed of sample
preparation for LC-MS analyses. Further, the system’s unattended operational
capabilities provide ample opportunities to develop novel and improve existing methods
to further our NIH funded research. All essential facilities required to install the
instrument are in place and the university is committed to maintain it for its continued
use well beyond the manufacturer’s warranty.

Public health relevance
Project Narrative Wayne State University Lipidomics Core Facility is requesting an automated sample preparation system to assist Liquid Chromatography – Mass Spectrometry (LC-MS) based lipid analysis services to NIH-funded researchers. Sample preparation for LC-MS is a labor-intensive process where automation will be immensely valuable to enhance accuracy, reproducibility, and reliability while increasing the sample throughput.